We Are All Scientists - promotes precision medicine and health research in Indigenous communities through a large scale multimedia campaign and building of strategic partnerships with schools and TCUs

2. Abstract
The American Indian Science and Engineering Society (AISES), founded in 1977, boasts the
largest reach to engage with AI/AN and Indigenous communities in science, technology,
engineering, and mathematics (STEM) with a network of more than 6,800 individual members,
202 higher education chapters, 20 professional chapters, 239 affiliated PK-12 schools serving
over 55,000 Indigenous students, and three tribal chapters. AISES anticipates continued growth
and therefore, proposes to meet the needs of AOI 3 - Task 1 by building on its extensive AI/AN
network with specific efforts to promote precision medicine and health research in Indigenous
communities. Through the creation of a multimedia campaign – We Are All Scientists -- featuring
content universally promoting Indigenous science education and research and a multi-year goal
of developing an open learning network of Indigenous students, educators, and professionals
who can exchange information, resources, and reciprocal support, AISES is poised to be the
leader in creating pathways for health research engagement among AI/AN and Indigenous
communities. The multimedia campaign is threaded throughout other programmatic elements of
the “We Are All Scientists” project as a tool to recruit a cohort of 20 Indigenous teachers and
teachers of Indigenous students and provide culturally relevant resources for teaching health and
data sciences. AISES will facilitate collaboration among Tribal Colleges and Universities
(TCUs) and Native American Serving Non-Tribal Institutions (NASNTIs) and interested
organizations to increase the opportunities for faculty and Indigenous researchers to engage in
precision medicine research and create diverse opportunities for Indigenous students to engage in
health and data science research.